Training for Industrial Hygiene Professionals and Researchers

Project Summary/Abstract
The Department of Occupational and Environmental Health (OEH) at the University of Oklahoma Health
Sciences Center (OUHSC) Hudson College of Public Health provides graduate education leading to the Master
of Science (MS) degree in Industrial Hygiene and Environmental Health Sciences (IH/EHS) and the Doctor of
Philosophy (PhD) degree in Occupational and Environmental Health.
The MS in IH/EHS at OUHSC is one of only four ABET-accredited masters level industrial hygiene
programs in the south central United States. The goal of the MS in IH/EHS is to prepare professional
practitioners to apply scientific knowledge to the anticipation, recognition, evaluation, and control of
environmental hazards or stresses affecting human health. The MS curriculum, which emphasizes both
quantitative skills and effective communication, consists of 48 semester hours of coursework, including
masters thesis research and a field practice experience, and can be completed in 22-24 months of full-time
study. The goal of the PhD degree in OEH is to prepare graduates to impart and/or add to knowledge in
occupational health through careers in academia or research. The PhD curriculum includes advanced didactic
coursework in environmental sciences, epidemiology, biostatistics, and research methods related to
occupational health, and a doctoral dissertation within the broad field of occupational and environmental
health.
The specific aims of the proposed renewal of the NIOSH training project grant (TPG) are: (1) to attract
highly qualified and motivated students, including individuals with cultural or linguistic fluency related to
underserved populations, into the industrial hygiene profession; (2) to recruit students with diverse technical
backgrounds who are interested in entering the industrial hygiene field; and (3) to recruit and train very
promising research-oriented students in industrial hygiene research. TPG funds will be used to support six
traineeship slots per year, to be filled by full-time masters-level trainees and up to 2 full-time doctoral-level
trainees. Trainees in the MS program may be supported on the TPG for up to 24 months. Trainees in the
PhD program may be supported for up to 5 years.
Oklahoma colleges have relatively high American Indian enrollments reflecting the state's unique ethnic
mix, presenting an excellent pool of well qualified prospective trainees from under-represented minorities.
Recruitment for the MS program will also target individuals with work experience in the health professions,
engineering, chemistry, and environmental science who wish to make the transition into industrial hygiene
practice. Recruitment for the PhD will target highly qualified individuals with BS or MS degrees in science or
engineering that provide a solid foundation for industrial hygiene research.

Public health relevance
Project Narrative/Public Health Relevance Currently there are not enough people trained in industrial hygiene practice and research to protect workers by identifying, evaluating, and controlling occupational hazards. The University of Oklahoma Health Sciences Center offers an ABET-accredited Master of Science degree in Industrial Hygiene and Environmental Health Sciences and a PhD degree in Occupational and Environmental Health. The training project grant will provide tuition and stipend support to attract students of diverse technical and cultural backgrounds into the industrial hygiene profession, enable them to rapidly enter the occupational safety and health professional workforce, and prepare a new generation of industrial hygiene faculty and researchers.